Supplement: Improving Small Molecule Synthesis by Controlling Reactions between Transition Metals and Carbon-Heteroatom Electrophiles

PROJECT SUMMARY
Multiply-substituted heteroarenes are ubiquitous in small molecule drugs. Transition metal-
catalyzed cross-coupling reactions are a common strategy used to elaborate these motifs during
the synthesis of small molecules for biomedical research. However, controlling site selectivity of
cross-coupling is critical if multiple substituents need to be installed, and a key goal of this project
is to address this challenge. Cross-coupling reactions of dihalogenated heteroarenes tend to obey
well-established selectivity preferences, and methods to invert selectivity are scarce or non-
existent. For example, palladium-catalyzed cross-couplings of 2,4-dihalopyrimidines always lead
to cleavage of the C4–halide bond. Preparation of the complementary products that would result
from C2–halide cleavage is not possible through cross-coupling methods, and instead requires
more circuitous synthetic strategies. However, a strategy for C2-selective cross-coupling of 2,4-
dihalopyrimidines was recently discovered involving unconventional reaction conditions. The
proposed supplement will allow the purchase of a ReactIR for monitoring reaction kinetics in order
to understand the mechanism behind the unique selectivity of this reaction and facilitate
expansion of this C2-selective manifold to diverse classes of cross-couplings. The ReactIR will
also enable elucidation of kinetics for other reactions studied under this award.

Public health relevance
The goal of this project is to streamline access to pharmacologically relevant compounds by developing new catalytic methods for organic synthesis. The new methods developed through this project have the potential to make small molecule synthesis more efficient, thereby decreasing the cost of lead identification and optimization in the drug discovery process. A new ReactIR instrument is requested that will advance the project goals and enable new discoveries.